DNA Replication Checkpoint in Fission Yeast

PROJECT SUMMARY/ABSTRACT .
DNA replication checkpoint is a cell signaling pathway operating in all eukaryotes that monitors normal S phase
progression and in response to perturbed DNA replication, activates cellular responses to prevent irreversible
replication fork arrest, genomic instability, and cell death. The checkpoint senses the perturbed replication,
maintains the genomic stability under stress and thus functions as an important anticancer barrier. Many
anticancer drugs work by interfering with DNA replication and their efficacy is therefore influenced by the
checkpoint status of cancer. Despite its importance in disease prevention and cancer chemotherapies, we still
do not fully understand the checkpoint initiation process at the replication forks, nor do we know exactly how the
checkpoint protects the fork functions under stress. As an established model for studying the cellular
mechanisms that are conserved in humans, fission yeast offers several benefits for this research. The goal of
this project is to investigate the newly screened checkpoint mutants in fission yeast with particular emphasis on
two objectives: (1) understand the mechanistic underpinnings of checkpoint initiation at the perturbed forks, and
(2) uncover the essential molecular details of the checkpoint-regulated fork protection. As a starting point, we
have developed a combined approach of forward genetics and biochemical analysis and have identified several
new mutants with various checkpoint initiation defects under replication stress. We have also screened a large
collection of mutants that are defective in fork protection. Guided by our strong preliminary and published data,
we will conduct in vivo and in vitro studies under the first objective to investigate how the checkpoint sensor
kinase Rad3(ATR) signaling is affected by mutations in the Rad3-Rad26 complex, the RecQ helicase Rqh1, the
Smc5/6 complex, and the RPA complex. Under the second objective, we will investigate how the activated
checkpoint regulates DNA polymerase e on the leading strand and other yet-to-be identified targets for fork
protection. The long-term goal of this research program is to provide a comprehensive understanding of the
replication checkpoint that involves three primary areas of inquiry: First, by using our newly improved genetic
method, replication proteins with conserved checkpoint functions will be identified. Second, reconstitution of the
checkpoint pathway in vitro using purified proteins that can properly recapitulate the in vivo data we and others
have obtained. Third, as we show in the studies on Rqh1, conservation of the checkpoint mechanisms in human
cells will be evaluated. Overall, this research program will bring much improved clarity to the molecular
mechanisms of the replication checkpoint in fission yeast as well as in mammalian cells. The proposed research
is significant because of its relevance to genome instability, oncogenesis, and cancer chemotherapies.

Public health relevance
PROJECT NARRATIVE . This proposed research is relevant to public health because the goal of understanding the molecular mechanisms of the evolutionarily conserved DNA replication checkpoint is to increase our knowledge about genome instability, oncogenesis, and cancer chemotherapy.